Toward Understanding the Role of the Polycomb Complex in Skin Control

Project Summary
Hair follicle stem cells (HFSCs) have the unique ability to generate new hair follicles throughout the lifetime
of an organism. When the growth of a new hair follicle occurs, HFSCs are activated; they proliferate to fuel the
production of a new follicle and quickly return to quiescence. While the means by which this transition between
quiescence and activation is regulated remain elusive, identification of these processes is critical, because
abnormal HFSC activation has implications in hair loss, aging, and cancer.
Polycomb repressive complexes (PRC) 1 and 2 are chromatin transcriptional regulators that are essential
for maintaining stem cell identity. By performing loss-of-function studies, we showed that loss of PRC1 in
HFSCs results in premature activation of HFSCs and the induction of hair growth, whereas loss of PRC2 leads
to a prolonged HFSC quiescence and delayed hair growth. These data show the critical and opposing roles of
Polycomb complexes in regulation of HFSC quiescence. This is an intriguing observation because PRC1 and
PRC2 are thought to act together, and, in most systems, the loss of either PRC1 or PRC2 results in identical
phenotypes. We hypothesize that PRC1 and PRC2 maintain the delicate balance of quiescence and activation,
but their mechanism of action is different than what was previously reported.
In Aim 1, we will determine the molecular mechanisms by which PRC2 fine-tunes HFSC quiescence. By
performing RNA-seq, we identified that Wnt inhibitors Notum and Sfrp2, and BMP receptor Bmpr1b are
upregulated in the PRC2-null HFSC. Because Wnt inhibition and Bmp activation are known to promote HFSC
quiescence, we hypothesize that expression of these genes leads to delayed HFSC activation. Here, we will
analyze whether expression of Notum, Sfrp2, and/or Bmpr1b promotes HFSC quiescence and recapitulates
the PRC2-null phenotype. In Aim 2, we will examine cooperation between repressive PRC1 and PRC2
functions in control of HFSCs. Our recent studies showed that PRC1 and PRC2 have additive gene-repressive
roles and that only loss of both leads to complete de-repression of PRC1/2 target genes. Here, we will ablate
repressive functions of both PRC1 and PRC2 complexes in HFSCs, analyze the phenotype, and determine
molecular mechanisms of PRC1/2 control of HFSCs. In Aim 3, we will examine noncanonical gene-activating
roles of PRC1 in promoting HFSC quiescence. Because loss of PRC1 and PRC2 show opposing phenotypes,
respectively, we hypothesize that PRC1 functions independently of PRC2 to promote the expression of genes
that influence HFSC quiescence. Here, we will identify genes that are under the control of PRC1 in HFSCs by
performing RNA-seq and ChIP-seq studies and test whether downregulation of said genes results in
precocious HFSC activation. The completion of these studies will define how Polycomb-mediated gene
regulation fine-tunes the delicate balance between quiescence and activation in HFSCs.

Public health relevance
Project Narrative Hair follicle stem cells (HFSCs) are multipotent epithelial stem cells that fuel the production of hair follicles throughout the life of an organism. We have recently identified that the key chromatin regulator, the Polycomb complex, not only plays a critical role in HFSCs but also exerts its function via a novel mechanism of gene regulation. By dissecting the molecular mechanisms of Polycomb-mediated regulation of HFSCs, we aim to gain insight into the regulation of HFSC during normal homeostasis as well as uncover processes that go awry in human diseases such as cancer.